RNA/PROTEIN INTERACTIONS REGULATING MRNA STABILITY

DESCRIPTION (Adapted from investigators's abstract) The overall objective of this proposal is to further the understanding of the determinants that regulate globin mRNA stability. This proposal has three main aims: 1) to identify all the alpha complex proteins both biochemically and genetically; 2) to functionally characterize the alpha-globin mRNA stability mechanisms by using an alpha-complex dependent in vitro mRNA decay system; and 3) to identify additional mRNA(s) bound by and possibly regulated by the alpha complex.